Mechanisms of Thin Filament Regulation by Myosin Binding Protein-C

ABSTRACT
Cardiac myosin binding protein-C (cMyBP-C) is an essential regulator of heart function that is
necessary for normal systolic and diastolic heart function and for enhanced contractility in response to inotropic
agonists that phosphorylate cMyBP-C through numerous signaling pathways. Whereas phosphorylation is
associated with cardiac protection, hypo-phosphorylation is consistently found in heart failure. Mutations in
MYBPC3, the gene encoding cMyBP-C, are also the most common cause of hypertrophic cardiomyopathy
(HCM), a disease with a prevalence of ~1:500. However, despite its significance to cardiac health and disease,
there is still remarkably little known regarding how cMyBP-C mediates its functional effects or how cMyBP-C
phosphorylation increases cardiac contractility in response to inotropic stimuli. Work from our 3 labs has shown
unequivocally that cMyBP-C directly activates the thin filament in muscle sarcomeres in the same way as
myosin cross-bridges. Our data thus demonstrate cMyBP-C effects to augment contraction or delay relaxation
are due to direct effects of cMyBP-C to shift tropomyosin to an activated state on the thin filament. Here we
take advantage of the revolution in cryo-EM to reveal detailed structures of cMyBP-C interactions with the thin
filament and also with myosin-S1 for the first time. We will use cryo-EM reconstructions to identify key residues
that mediate interactions with thin filaments and myosin-S1 and will test model predictions using an arsenal of
functional approaches including a novel (“Spy-C”) method developed exclusively in our labs that allow us to
replace the N'-terminal domains of cMyBP-C in sarcomeres in situ. Using our structural maps, we demonstrate
proof of principle by identifying amino acids responsible for cMyBP-C activation of tropomyosin and show that
phosphorylation causes cMyBP-C domains to reposition on the thin filament. Specific aims will build on these
discoveries and combine our unique resources to: 1) Determine how individual cMyBP-C domains
communicate with neighboring domains when bound to the thin filament and myosin-S1, and 2) Define how
Ca2+ and phosphorylation modulate key regulatory interactions of cMyBP-C with the thin filament and myosin-
S1. By identifying the critical molecular interactions that control cMyBP-C binding to the thin filament and
myosin-S1 these studies will pave the way for future targeted approaches to modulate cardiac contraction and
relaxation.

Public health relevance
PROJECT NARRATIVE Cardiac myosin binding protein-C (cMyBP-C) is an essential regulatory protein in heart that is necessary for normal cardiac contraction and is required for increased contractility in response to fight-or-flight stimuli. The importance of cMyBP-C to cardiac function is further highlighted because cMyBP-C is altered during heart failure and mutations in the gene encoding cMyBP-C are the most common cause of hypertrophic cardiomyopathy (HCM), the leading cause of sudden cardiac death in young people. The proposed experiments will investigate specific mechanisms regarding how cMyBP-C influences muscle contraction by interacting with actin and myosin, the two proteins essential for force generation. Understanding these interactions will increase our understanding of fundamental mechanisms by which cMyBP-C regulates cardiac contraction.